Chemistry Animal Food Product Testing Analytical Track

Increasing the Capability and Capacity of Microbiological and Chemical Testing to Support an Integrated Food Defense and Food Safety System Chemistry Discipline, Animal Food Product Testing Analytical Track Project Summary / Abstract The Ohio Department of Agriculture (ODA) Consumer Protection Laboratory (CPL) proposes to participate in risk assessment of animal food products through surveillance testing and collaboration with state and federal regulators. The Plant Health division of ODA is the primary state regulatory sampling organization and has enjoyed a strong relationship with ODA-CPL in handling regulatory testing of animal feed for label claim verification and for possible contaminants. ODA-CPL proposes therefore to acquire 500 animal food samples for surveillance testing. The laboratory is prepared to perform GC-MS, LC-MS and ICP-MS screens for toxins, poisons, toxic metals and any other type of contaminant that might be present in animal feed samples. In addition, the laboratory will target specific types of commodity/hazard pairs identified by the FDA to be of potential interest for any given budget period, with an emphasis in the first year of focusing on toxic metals by ICP-MS. The laboratory agrees to provide timely reporting in the case of a presumptive positive to both the Plant Health division and to the FDA technical lead and project manager.